CHEMISTRY OF 2-ALKYNYLETHENYL KETENE

An unusual and potentially very valuable reaction has been discovered and is viewed as providing a synthetic entry to a variety of aromatic compounds, including some natural products which express antiartheroclerotic activity (ascofuranone, khellin). This chemistry involves the generation of the previously unknown (2-alkynylethenyl)ketenes and their subsequent ring closure to zwitterionic and/or diradical intermediates. These intermediates then proceed to stable products which are either aromatic compounds or quinones. It is anticipated that this research will result in the development of methodology which will allow the regiospecific synthesis of highly substituted aromatic compounds.